Developing Activatable Fluorescent Flavonoids for Vascular Imaging

Developing Activatable Fluorescent Flavonoids for Vascular Imaging
Project Summary/Abstract:
During the imaging applications, fluorescent probes may be away from their binding targets, or in excess,
thus giving background signals that affect the quality of imaging. Removal of the background signals often
requires the post-staining washing to remove the excess dye, which could be a limiting factor for some
applications. The proposed research seeks to improve the imaging process by developing flavonoid-based
imaging reagents that give nearly no fluorescence in aqueous solution. However, the fluorescence of these
dyes will be greatly enhanced during target-binding interaction, thus eliminating the need for post-staining
washing step. When being applied to wild-type zebrafish, the developed dye can penetrate into the fish’s body
and selectively target blood vessels, without using labor-intensive “dye injection”. Because zebrafish has
become a favorite model organism for studying vertebrate development and various human diseases,
discovery of these new imaging reagents for in vivo imaging could have large impact in the field of biological
studies. The experimental study aims to discover and synthesize these probes that exhibit selective binding
toward blood vessels. Discovery of such imaging reagents could lead to user-friendly probes for in vivo
imaging of blood vessels, which could facilitate the related study by using zebrafish model.

Public health relevance
Project Narrative Zebrafish has become a favorite model organism for studying vertebrate development and various human diseases. The proposed research focuses on the development of new imaging reagents, which could bind selectively to blood vessels to give large fluorescence turn-on. Success in the study could lead to novel imaging reagents, which enable simplified applications and could facilitate a wide range of developmental studies by using zebrafish model organism.